Targets and targeting of immunometabolism in chronic PM2.5 exposure

Project Summary
PM2.5 is a leading global risk factor for morbidity and mortality and is the leading environmental factor
implicated in cardiovascular disease. Recent data suggest that PM2.5 and/or traffic-related air pollutants may
play a role in chronic diseases such as Type 2 diabetes mellitus, that may in turn confer susceptibility to
cardiovascular disease and has been the topic of multiple systematic reviews and meta-analysis by us and
others. In a series of studies in animals and humans, we have provided convincing evidence linking PM2.5 to
pathways playing an etiologic role in cardiometabolic disease. Our findings and reviews have fundamentally
shaped the understanding of the effects of PM2.5 and its association with increased risk of cardiometabolic
disease. In particular, our group has demonstrated pro-atherogenic effects of chronic PM2.5 exposure, through
ROS and inflammation dependent pathways. Although our understanding of pathways contributing to
progression of disease has been dramatically enhanced, the mechanisms involved in the resolution of
inflammation and an understanding of how dysregulation of resolution pathways contributes to disease
progression has been limited. Identification of these mechanisms could pave the way for new opportunities to
target non only air pollution mediated cardiovascular risk but other pervasive health risks. Through the
implementation of three specific aims this proposal seeks to: 1) characterize air pollution-induced changes in
inflammation resolution pathways; 2) determine to what extent these pathways overlap with dietary
manipulation; 3) identify potential intervention strategies to promote upregulation of conserved resolution
pathways in response to air pollution-induced inflammation.

Public health relevance
Relevance to Public Health Fine particulate matter <2.5 µm (PM2.5) air pollution is a major environment-related health threat that leads to both acute and chronic diseases and a risk factor for cardiovascular disease. Very little is known on the effects of PM2.5 cessation or how to alleviate the detrimental effects of the air pollution through therapeutic or dietary interventions. This proposal will investigate a relationship between PM2.5 and resolution of inflammation caused by PM2.5 through a variety of approaches, including diet switch and a novel pharmacological mimic of exposure cessation.